Stress-induced loss of BIV-spectrin regulates cardiac fibroblast function and long-range communication

Project Summary
Myocardial infarction (MI) is a major cause of death and disability worldwide, affecting ~800,000 Americans
annually. Optimal healing of the damaged tissue requires the delicate balance, both spatially and temporally, of
inflammatory and reparative mechanisms to create the fibrotic scar. Cardiac fibroblasts (CFs) are the main
contributor to fibrotic remodeling. Following ischemic injury, CFs transition into an activated phenotype that is
characterized by increased proliferation, migration to the infarct region, and secretion of fibrotic proteins and
paracrine signals. At the same time, dysregulation of the CF response to injury can promote pathological fibrosis,
increased risk for arrhythmia, and cardiac dysfunction. While there has been many studies exploring the diverse
signaling cascades and stressors that cause CF activation, how these stressors regulate the CF phenotype and
paracrine signal generation, both spatially and temporally, remain elusive.
Recent work identified stress-induced loss of the cytoskeletal protein, βIV-spectrin, to be an important step in CF
activation and fibrosis3. Further, loss of βIV-spectrin was found to depend on Ca2+/ calmodulin-dependent protein
kinase II (CaMKII). A broader role has been identified for βIV-spectrin/CaMKII in regulating CF gene expression
through an interaction with signal transducer and activation of transcription 3 (STAT3)3,4, a signaling molecule
and transcription factor that promotes profibrotic mechanisms. Specifically, CaMKII is activated and promotes
loss of βIV-spectrin and redistribution of STAT3 to the nucleus that lead to changes in gene expression. Together,
this leads to the hypothesis that the βIV-spectrin/STAT3 complex acts as a signaling node that is necessary for
regulating cardiac fibroblast activation, recruitment, and scar formation post MI. To evaluate this hypothesis, Aim
1 will identify the role of the βIV-spectrin/STAT3 complex in CF activation and long-range communication. CFs
will be subjected to both biomechanical stretch and neurohormonal stimuli, correlating to MI pathophysiology, to
evaluate the effects on CF activation and exosome secretion. To understand how remote CFs migrate to the
infarct area, long-range communication signals from spectrin-deficient CFs will be characterized and cultured
with fresh CFs to see if they lead to activation. Additionally, this project will offer mechanistic insight into the
spatiotemporal regulatory role of spectrin-based proteins in modulating exosome secretion following chronic
stress. Lastly, Aim 2 will subject spectrin-preserved and spectrin-deficient mice to MI and evaluate the effects
on scar formation and maturation. These studies will offer insight into how specific stress combinations tune the
process of fibrotic remodeling following MI, and how these regulatory proteins can affect the overall outcome of
MI patients.

Public health relevance
Project Narrative A heart attack occurs when blood supply to the heart muscle is lost, causing cell death, scarring, and long-term structural changes to the heart. We have identified an intracellular protein that regulates scar formation and cell communication after a heart attack. Our goal is to identify therapeautic interventions to improve long-term outcomes for patients.